Multilevel determinants of prenatal syphilis screening policy implementation

PROJECT SUMMARY/ABSTRACT
This R03 proposal aims to explore the multilevel determinants of the implementation of prenatal syphilis
screening policies into clinical practice among obstetric providers. Professional organizations have endorsed
evidence-based guidelines (“guidelines”) to screen for syphilis at prenatal visits and reduce the burden of these
infections, but states can also regulate their own screening requirements through legislation and policies
(“policies”). The guidelines and policies are inconsistent and differ widely in their scope, populations of focus,
recommended timing of screening, and determinants of risk (ACOG, 2017; Curry et al., 2018; Workowski et al.,
2021). To identify leverage points and enact systems-level change, exploring the multi-level factors influencing
implementation of these prenatal syphilis guidelines and policies into obstetric care is essential. The long-term
goal is to increase rates of syphilis screening at prenatal visits, thus reducing the rates of congenital syphilis in
Texas. The objective is to identify implementation strategies for obstetric providers to facilitate the prenatal
syphilis screening policies into clinical care. This study will align with the steps of Implementation Mapping, and
we will form a Planning Board (n=10) comprised of obstetric providers across various practice settings
(physicians, nurse practitioners, nurse midwives, registered nurses), hospital management, clinic administrators,
and prenatal patients. The Planning Board will participate in all study aims (Fernandez, 2019). Aim 1: Assess
the multilevel determinants of prenatal syphilis screening policy implementation. Guided by the
Consolidated Framework for Implementation Research (Damschroder et al., 2009), in-depth interviews will be
conducted with obstetric providers, hospital/clinic administrators, and prenatal patients in Texas (n=45; Task 1
of Implementation Mapping). The multilevel determinants, barriers, and facilitators to implementation of syphilis
screening policies into clinical care will be assessed. Aim 2. Develop a multilevel prenatal syphilis screening
policy implementation strategy. Using a modified Delphi approach, the Planning Board will develop a logic
model of change, expected outcomes, performance objectives, and matrices of change (Task 2 of
Implementation Mapping). The Planning Board will choose theory and/or evidence-based methods to influence
the identified determinants and subsequently select implementation strategies to operationalize those methods
based on Powell's compilation of implementation strategies (Task 3 of Implementation Mapping). This project will
enhance knowledge of contextual and systems-level determinants influencing obstetric providers practice
behaviors and hospital management decision-making. It will also provide information on implementation of
syphilis policies in Texas - the state with the highest congenital syphilis rates in the country. Upon preliminary
development of a multilevel implementation strategy, the research team will submit an implementation science-
focused R01 during Year 2 to complete Tasks 4-5 of Implementation Mapping, including experimentally testing
the proposed strategy through a hybrid Type II effectiveness-implementation study design.

Public health relevance
PROJECT NARRATIVE Syphilis screening during prenatal care visits is a significant public health need given the increasing prevalence, impact on women's and infant's health, and links with adverse birth outcomes and other health conditions across the life course. Recent increases in congenital syphilis infections have warranted state-level policy changes in prenatal screening recommendations to reduce these outcomes; however, barriers and facilitators to implementing these policies into clinical practice remain unknown. This project aims to address this gap by assessing the multilevel determinants that influence implementation of syphilis screening policies and identify implementation strategies for obstetric providers to facilitate translation of these policies into clinical care.